KOMP2-Phase 2 Production and Phenotyping by the DTCC Consortium

Completion of KOMP2 Project Goals Interrupted by the COVID-19 Pandemic at the DTCC UM1OD023221 Administrative Supplement August 1, 2021 – July 31, 2022 ABSTRACT The outbreak of emerging severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) disease (COVID-19) early in 2020, the 10th year of the KOMP2 Project, caused a suspension of all but essential in-person research activities for several months by DTCC Consortium members at UC Davis and The Centre for Phenogenomics (TCP). Restrictions during the pandemic curtailed mouse breeding and phenotyping activity in order to maximize physical distancing and operate in a way that mitigates viral transmission and spread. As a result, work at UC Davis and TCP was severely curtailed for most of the year, limited to maintaining a lower-than-expected level of breeding of cohorts and reduced phenotyping of mice. Consequently, the DTCC Consortium is short of the total number of lines phenotyped. Therefore, the DTCC Consortium will be unable to fulfill its phenotyping goals with available funds and thus will not meet project expectations by the end of the current project year on July 31, 2021. Commensurate with the disruption in work activities at UC Davis and TCP, scientific and budgetary planning processes were similarly stalled at NIH which prevented it from publishing a KOMP-related funding opportunity announcement in 2020. As a result, the DTCC-KOMP2 Consortium was denied the opportunity to apply for a competitive renewal. The aim of this administrative supplement request is to finish the generation of the DTCC Consortium obligation to deliver 1000 mutant mouse lines using CRISPR/Cas9 technology, perform phenotyping assays, conduct quality control assessments, cryopreserve germplasm, and make mice and data readily available to the research community. Although the goal of producing and cryopreserving 1000 mutant mouse lines has already met, the phenotyping goals will not be. As work restrictions imposed in response to the pandemic lift, it is expected that adult and embryo phenotyping pipelines will be fully restored later during this calendar year. In this context, projections for completion of the project have been adjusted to enable completion of all KOMP2-Phase2 project goals during a 1-year extension of activities ending July 31, 2022. Therefore, the DTCC Consortium requests administrative support for a 1-year funded extension of the KOMP2-Phase2 grant for activities related to the Specific Aims of the Parent Grant activities, including technical personnel, phenotyping supplies, mouse per diem and maintenance costs, informatics support, and project coordination. These activities will enable completion of cohort production and phenotyping of 26 early adult homozygous and 46 early adult heterozygous lines, 31 embryo lethal/subviable lines, and 8 late adult homozygous lines. In addition, another 28 embryo subviable lines will be reanimated to generate embryos for imaging that were delayed and spoiled due to COVID-19. Completion of all these activities will enable the DTCC Consortium to fulfill all of its obligations to the KOMP2-Phase2 project.

Public health relevance
Completion of KOMP2 Project Goals Interrupted by the COVID-19 Pandemic at the DTCC UM1OD023221 Administrative Supplement August 1, 2021 – July 31, 2022 PROJECT NARRATIVE This 1-year funded extension will enable the DTCC Consortium to fulfill its original grant goals of producing and phenotyping 1000 knockout mouse lines for the KOMP2-Phase2 project which were delayed as a result of the COVID-19 pandemic. Data, images, and information resulting from this work will confirm known and reveal new in vivo functional annotation of genes that play a role in health and disease in humans. The completion of this resource and data set will add valuable and important new information on the function of genes in the mammalian genome.